CHAPS Cohort Maintenance

Abstract
The Children’s Health and Air Pollution Study (CHAPS), one of the NIEHS/EPA co-sponsored Children’s
Environmental Health Centers, has focused on the effects of air pollution on children growing up in the San
Joaquin Valley of California, one of the most polluted areas in the country. CHAPS involves the recruitment
and follow-up of two age-specific cohorts of children, an infant cohort recruited while in utero and a child cohort
recruited at ages 6-8. The primary research goal for both cohorts is to investigate the effects of exposure to
ambient air pollution, particularly polycyclic aromatic hydrocarbons (PAHs) and other traffic-related pollutants,
on immune and metabolic dysregulation. We have recruited over 200 children in each of the two cohorts and
are in the process of following them over a 2-year period. We have collected the following biomarker data:
anthropometry; blood pressure (BP); spirometry in the child cohort; assays in blood samples for immune
regulation, metabolic function, and systemic inflammation; and a urinary assay for oxidative stress. To date,
our research team has a) confirmed a novel epigenetic mechanism by which ambient PAHs and other
pollutants contribute to allergic disease in children through hypermethylation of the forkhead box P3 gene
(FOXP3), b) confirmed that exposure to ambient PAHs is associated with reduced lung function in children,
and c) shown that exposure to traffic-related air pollutants, including ambient PAHs, is associated with BP,
hemoglobin A1c (HbA1c), BMI-for-age, and urinary 8-isoprostane. Whether our findings in young children will
predict future allergic disease and metabolic syndrome as the children age is an important and currently
unanswered question. To address this question we propose in our application for Environmental Epidemiology
Cohort (EEC) funding the following specific aims: 1) to retain and continue to follow both CHAPS infant and
child cohorts over the next 5 years; 2) to maintain and strengthen data management infrastructure; 3) to
maintain and enrich the CHAPS repository of biospecimens; 4) to conduct validation, pilot, and feasibility
studies using existing data and samples; and 5) to encourage data sharing. The well-characterized CHAPS
cohorts provide the opportunity to study the health effects of traffic-related air pollution from birth through
adolescence in a low-income, predominantly Latinx community. The proposed EEC will provide evidence in
support of policies to protect the health of such vulnerable communities.

Public health relevance
Project Narrative The proposed Children’s Health and Air Pollution Study (CHAPS) Environmental Epidemiology Cohort will provide the opportunity to study the adverse health effects of traffic-related air pollution from birth through early adulthood in a low-income, predominantly Latinx community. We have previously demonstrated both immune and metabolic dysfunction in young children. Whether our findings in young children will predict future allergic disease and metabolic syndrome as the children age is currently an unanswered question of considerable public health importance.